Improvements in Mentalizing as a Mechanism of Change in Psychotherapy for Depressed and Suicidal Adolescents

As the second leading cause of death for U.S. teens, adolescent suicide is a significant
public health concern. A number of recent studies show that deficits in “mentalizing,” or the ability
to make generally accurate inferences about the thoughts, emotions, behaviors, and intentions of
others, are linked to adolescent suicide risk. One study also demonstrated that mentalization-
based treatment reduced rates of adolescent non-suicidal self-injury (NSSI). However, none of
these studies used the Adult Attachment Interview (AAI), the gold standard for deriving estimates
of mentalizing, and no treatment studies have examined whether improvements in adolescent
mentalizing reductions in suicide risk symptoms (e.g. decreases in frequency and intensity of
ideation, intent, number of attempts). The objective of the proposed study is to determine whether
improvements in adolescent mentalizing predict suicide risk symptom reduction over the course
of 16 weeks of psychotherapy. The study has two specific aims: 1) Determine whether adolescent
mentalizing improves over the course of psychotherapy for adolescent suicide risk; and 2)
Determine whether improvements in mentalizing predict and mediate improvements in suicide
risk symptoms. The study will capitalize on secondary data from a recently completed RCT
examining two treatments for adolescent suicide risk (Attachment Based Family Therapy and
Family-Enhanced Non-Directive Supportive Therapy) (N = 129). Both treatments were similarly
efficacious in reducing suicide risk symptoms. All adolescents completed pre and post-treatment
AAIs, which will be coded for mentalizing. The data set includes pre- and post-treatment data
(weeks 0 and 16), mid-point data (weeks 4, 8,12), and data through 1-year of follow-up (weeks
20, 32, 40, 52). This rich data set will allow for pre-post-test analyses, longitudinal growth curve
modeling, and mediation analyses.
Mentalizing is a core component of social understanding and synonymous with the “ability
to understand mental states,” identified a key NIMH research domain sub-construct, under the
broader construct of “perception and understanding of others. Accomplishing the aims of the
proposed study will significantly impact knowledge about a treatment target that may be
particularly important for adolescents at risk for suicide and will be a first step towards a future
R01 submission aimed at: 1) building provider-friendly tools to assess mentalizing as a marker of
treatment progress for youth suicide; and 2) refining youth suicide interventions to target and
measure improvements in mentalizing.

Public health relevance
Suicide is the second leading cause of death for teens in the United States; more than one million teens make a suicide attempt and over 6000 teens lose their lives to suicide each year, resulting in enormous costs for individuals, families and communities. The objective of the proposed study is to determine whether improvements in adolescent mentalizing (the ability to make generally accurate inferences about the thoughts, emotions, behaviors, and intentions of others), over the course of 16 weeks of psychotherapy, predict adolescent suicide risk symptom reduction. If we can identify improvements in mentalizing as a predictor of suicide risk symptom reduction, we will have valuable new information to: 1) help create more effective risk screening tools; 2) better assess treatment progress; and 3) design more effective and targeted intervention and prevention programs.